Mechanisms of Somatostatin-Mediated Inhibition of Insulin and Glucagon

Somatostatin (SST) is a major inhibitory hormone that is capable of attenuating both glucagon and insulin
secretion from alpha (α) and beta (β) cells respectively within the pancreatic islet of Langerhans. However, there
is a critical gap in our understanding of the basic signaling mechanisms downstream of Somatostatin Receptor
(SSTR) activation, and how these favor the inhibition of insulin secretion under some circumstances and the
inhibition of glucagon secretion under others. Through transcriptomic analysis of purified α and β cell populations
I have identified key differences and potential similarities between both which may begin to explain their cell
specific SST response. Central to these observations, the SSTR profile which provides the input signal between
either cell type is fundamentally different between α and β cells, with both cell types expressing SSTR3 on
primary cilia, while α cells additionally express SSTR2 on their cell surface. Somatostatin signaling is typically
suggested to lead to the inhibition of calcium and/or cAMP in the islet, but the relative importance of SST’s effect
on these parallel signaling cascades is not understood. Furthermore, I have identified a novel SSTR mediated
effector mechanism that actively drives the remodeling of filamentous actin (F-actin) with implications for
secretory granule exocytosis. As such, my central hypothesis is that selective activation of SSTR3 on β cells
and SSTR2 or SSTR3 on α cells will attenuate insulin and glucagon secretion via distinct effects on the quality
and kinetics of Ca2+ and cAMP responses and downstream F-actin polymerization. I will pursue this hypothesis
through two separate aims anchored by high throughput functional imaging of intact islets. First, I will leverage
transgenic mouse lines in which fluorescent reporters of secondary messengers will be delivered to strictly α or
β cells. These islets will then be subjected to individual SSTR agonists and antagonists to understand the
individual contributions of identified cell specific SSTRs. Second, fluorescent reporters of F-actin dynamics will
be employed in live imaging experiments to functionally determine the contribution of SSTR activation on F-actin
polymerization and remodeling. These results will be coupled next generation sequencing data of purified
populations of α and β cells treated with SST and SSTR type specific antagonists. The results of this aim will
characterize an underlying F-actin response to SST contributing to overall hormone attenuation. These
approaches are innovative as they leverage the power of high throughput functional imaging of large populations
of cells to characterize both a novel mechanism and cell type specific response in high resolution. Collectively,
the results of these aims are significant as they will result in a more complete understanding of the mechanisms
by which SST succeeds in attenuating insulin and glucagon release under different metabolic conditions. This
understanding carries significant weight in developing cell specific SSTR agonists aimed at attenuating specific
cell populations, with implications in targeted treatment of type I and II diabetes affecting over 30 million
individuals in the United States of America.

Public health relevance
The proposed research is relevant to public health because there is currently no clear understanding of the mechanistic underpinnings and roles of different inhibitory somatostatin receptor subtypes in the alpha and beta cells of the pancreatic islet. The mechanisms proposed complement existing understandings of paracrine signaling within the islet and integrate these with novel observations of filamentous actin reorganization following somatostatin receptor activation. Thus, the proposed research is relevant to NIDDK’s mission because it directly addresses the mechanism by which somatostatin inhibits insulin and glucagon secretion, which can be leveraged to improve the quality of life for millions of Americans with diabetes.